BIOLOGICAL THERAPEUTICS PRODUCT DEVELOPMENT SUBJECT MATTER EXPERT CONSULTING SERVICES TO SUPPORT THE DEVELOPMENT OF CELL AND GENE THERAPY PRODUCTS

The NINDS has a need for biological therapeutics development subject matter expert (SME) consultants to provide technical recommendations and advice that will support the translational development of novel therapeutics (Biologics) for NIH drug discovery and development programs. The support included in this contract will cover chemistry, manufacturing, and controls (CMC) expertise.

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.

Public health relevance
This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.